K-B focusing mirror system and monochromator upgrade for the BioCAT Beamline 18ID at the Advanced Photon Source.

The purpose of this administrative supplement request is to allow us to procure a “K-B focusing mirror system
and monochromator upgrade for the BioCAT Beamline 18ID at the Advanced Photon Source.” New focusing
mirrors are required to take full advantage of the improved source characteristics of the upgraded Advanced
Photon-Source (APS-U). A new commercially supported monochromator is required to replace our 27 year old
monochromators that are no longer supported by the APS and will provide improved beam stability
.

Public health relevance
The BioCAT resource will continue to provide state-of-the-art facilities with unique capabilities for muscle/fiber diffraction and macromolecular SAXS to the bio-medical and structural biology community. The purpose of this proposed administrative supplement is to new X-ray optical components that will provide better performance and mitigate obsolescence.